University of Washington (UW) Mendelian Genomics Data Coordinating Center

PROJECT SUMMARY
Despite significant advances made in understanding the genetic basis of the more than 10,000 estimated
Mendelian conditions in recent decades, further scientific collaboration and discovery is required to identify the
full set of Mendelian diseases and their underlying genetic causes. To build on the success of the Centers for
Mendelian Genomics by using further technological, methodological, and data-sharing innovations, NHGRI is
establishing a new Mendelian Genomics Research Consortium. As Data Coordinating Center for this
Consortium, we propose to further the discovery and characterization of Mendelian conditions by achieving
four main aims. (1) Managing the release of molecular and phenotypic data generated or collected by the
Consortium's Research Centers, featuring semi-automated and scalable quality control procedures that will
validate incoming data against collaboratively-established standards and requirements. We will facilitate data
sharing within the Consortium and the broader scientific community by ensuring that curated data are
submitted to appropriate repositories including AnVIL, ClinVar, and Matchmaker Exchange. (2) Supporting
program outreach through a Consortium website that highlights program progress and discoveries and
enabling connections among researchers, clinicians, and families. We will also oversee education, training,
and mentorship opportunities. (3) Coordinating logistics for the Consortium, including organization of virtual
and in-person meetings and administrative support for all Consortium-wide activities. (4) Overseeing an
Opportunity Fund, administering up to 5 awards in each of years 2-5 of the Consortium, to support novel and
scalable approaches to functional follow-up on candidate variants. To achieve these four main aims, we
propose innovative approaches, including leveraging emerging cloud-based systems for the storage and
analysis of human genetic data and integrating international data sharing standards to ensure that data is
findable, accessible, interoperable, and reusable (FAIR). Furthermore, we bring a unique blend of expertise
across the fields of data science, cloud systems, biostatistics, bioethics, clinical genetics, and Mendelian
discovery to the Consortium, and our application rests on 13 successful years of experience and expertise
serving as Coordinating or Analysis Centers for 7 large-scale genetic and biomedical projects. Through support
and coordination of this Consortium, we will help yield the benefits of identifying the genetic basis of Mendelian
conditions to support diagnosis, therapy, and further delineation of syndromes. Further public health benefit will
accrue via biological insights into Mendelian diseases that also advance our understanding of related common,
complex diseases.

Public health relevance
PROJECT NARRATIVE The NHGRI Centers for Mendelian Genomics (CMGs) have contributed substantial knowledge to the genetic basis of thousands of Mendelian diseases over the past decade, but diagnostic rates across the full set of conditions remain low. The NHGRI Mendelian Genomics Research Consortium will build on the CMGs' success by applying technological and data-sharing innovations to accelerate the further discovery and genetic characterization of Mendelian conditions. As the Data Coordinating Center for the Consortium, we will lead efforts to establish Consortium-wide data standards, utilize cloud-based resources to enable rapid data sharing among Consortium members and timely release to the broader scientific community, manage the opportunity fund supporting scalable functional studies of candidate genes and variants, and coordinate program logistics and outreach.